Addressing Chemoresistance in Pancreatic and Ovarian Cancers: Photodynamic Priming and Repurposing of Tetracyclines using Targeted Photo-Activable Multi-Inhibitor Liposome

ABSTRACT
The prognosis for patients with advanced stage ovarian or pancreatic cancer has remained dismal for
decades. The poor response rates result, in part, from resistance to salvage chemotherapies, including
topoisomerase I (Top1) inhibitors such as irinotecan and topotecan. The full potential of Top1 inhibitors is
hindered mainly by two mechanisms: (1) ATP-binding cassettes (ABC) transporters (i.e., P-glycoprotein and
ABCG2) that actively pump drugs out of cancer cells, and (2) Upregulation of the DNA repair enzyme, tyrosyl-
DNA phosphodiesterase 1, which resolves the topoisomerase I-DNA cleavable complexes to allow DNA
religation and cell proliferation. It is becoming increasingly clear that no single treatment is likely to overcome
this complex problem, and combination treatments of newly emerging modalities may offer the most promise.
Here, we introduce a complementary, two-pronged approach to address chemoresistance: (i) Employing
photodynamic priming (PDP) to damage ABC transporters, improve the delivery of Top1 inhibitors, and reduce
the normal tissue toxicity, and (ii) Repurposing tetracycline antibiotics to inhibit the DNA damage repair
enzyme tyrosyl-DNA phosphodiesterase 1. PDP is a clinically relevant, photochemistry-based modality that
involves light activation of photosensitizers to modulate nearby tissues or biomolecules without killing the cells.
This proposal leverages image-guided strategies and nanoscale engineering to develop Targeted Photo-
Activable Multi-Inhibitor Liposome (TPMIL) that co-delivers PDP, Top1 inhibitors, and tetracycline antibiotics in
the appropriate sequence with consideration of their mechanistic interactions. In addition to co-packaging Top1
inhibitors and antibiotics, TPMIL is surface modified with antibody-photosensitizer conjugates to target
epidermal growth factor receptor, which is frequently amplified in pancreatic and ovarian cancer. Using a novel
hyperspectral fluorescence microendoscope imaging system, we will longitudinally monitor photosensitizer
delivery and changes in ABC transporter expression to improve PDP and chemosensitization in vivo (Aim 1).
The mechanistic interactions between Top1 inhibitors and tetracycline antibiotics will be investigated in vivo,
with and without PDP (Aim 2). Biomarkers predictive of chemosensitization will also be identified. TPMILs will
be customized to target ovarian and pancreatic cancer cells while co-delivering photosensitizers, Top1
inhibitors, and tetracycline antibiotics (Aim 3). The safety and therapeutic efficacy of TPMIL will be determined
in PDX mouse models (Aim 4). We have demonstrated the clinical feasibility of PDP in patients with locally
advanced pancreatic cancer. For metastatic ovarian cancer, we envision a simple and feasible modification to
the standard clinical framework. TPMILs will be delivered intraperitoneally after surgical debulking of ovarian
tumors, and then light activated to trigger PDP and the release of chemotherapy and antibiotics. The
knowledge gained may play a transformative role in the development of improved therapeutic regimens that
are tailored to the molecular profile of advanced pancreatic and ovarian cancer in individual patients.

Public health relevance
NARRATIVE Advanced stage ovarian and pancreatic cancers with intrinsic or acquired resistance are considered incurable primarily due to the poor response rate of salvage chemotherapies, such as irinotecan and topotecan. The two main mechanisms that induce or promote chemoresistance are drug efflux mediated by ATP-binding cassette (ABC) transporters and DNA damage repair. This proposal will engineer the first light-activatable nanotechnology platform that combines photochemistry and drug repurposing strategies to selectively damage ABC transporters and inhibit DNA damage repair enzymes for improved outcomes.